Development of a Mechanism and Structure-Guided Methodology for De Novo Enzyme Design

Project Summary/Abstract
Naturally enzymes are characterized by their ability to accelerate chemical reactions by orders of
magnitude and with far greater specificity than those observed in aqueous solution. However, these catalytic
properties have yet to be realized in synthetic chemical or biological systems. While there have been many
recent advances in the de novo design of proteins, achieving the exquisite control of individual atoms and
functional groups necessary for enzyme catalysis remains a long-standing challenge and has relied on directed
evolution and high-throughput screening to improve upon designs. The first principles design of an active site
capable of substrate binding and catalysis with rates and affinities similar to those found in natural enzymes
would represent a breakthrough in our understanding of structure-function relationships and the origins of protein
(dys)function. A recent advance in the de novo design of small-molecule-binding proteins demonstrates the
ability to position non-covalent interactions, such as hydrogen bonds from a protein to ligand functional groups,
with sub-Å accuracy. Based on this methodology, it’s hypothesized that if non-covalent interactions can be
rationally designed for binding, then they can be directed towards achieving de novo enzyme design through
preferential TS-stabilization to achieve fast reaction rates. In order to test this hypothesis, enzymes capable of
the model Kemp elimination reaction will be de novo designed using a bottom-up approach to install a general
base and tune its reactivity, assemble an active site capable of substrate- and TS-analog-binding, and develop
a negative design strategy for preferential TS-stabilization. These fundamental insights will be directed towards
the first de novo metallo-β-lactamase, a model system for studying antibiotic resistance and protein evolution
with human health implications. Catalytic turnover of the large and highly polar β-lactam antibiotics provides a
sensitive test of our ability to design non-covalent interactions. This will be achieved by expanding upon the size,
asymmetry, and topology of designable protein scaffolds using a bioinformatic and function-guided design
strategy for multi-domain proteins, de novo design of a Zn2+- and substrate-binding site, and development of de
novo methods for preferential transition-state stabilization. The proposed investigations will be achieved using
both computational and experimental methods, starting from in silico approaches to benchmark the folding and
binding of reaction intermediates in designed proteins. Promising designs will then be expressed, purified, and
characterized in terms of their binding affinity and catalytic rate constants using isothermal calorimetry and optical
spectroscopies. These functional studies will be complemented by structural characterization using X-ray
crystallography and NMR spectroscopy to confirm the accuracy of the design methodology. Successful de novo
design of functional enzymes would represent a breakthrough in our understanding of structure-function
relationships and the role of non-covalent interaction in complex protein function.

Public health relevance
Project Narrative The scope of chemical reactions, incredible rates, and impressive selectivity of enzymes are essential for the maintenance of biological systems and human health. The evolutionarily-acquired protein structure, encoded genetically, enables the precise and efficient control of substrate specificity, binding, and catalysis through local non-covalent interactions to modulate function. Expanding upon naturally-evolved enzymes, the potential to design proteins from scratch enables fundamental insights into the origins of catalysis through structure- function relationships, providing opportunities to develop novel chemistries, make therapeutic discoveries, and explore the consequences of protein evolution.